Illuminating Function of the Understudied Druggable Kinome

Project Summary/Abstract
Kinases are among the most important drug targets and clinically significant kinase inhibitors have been
developed for multiple diseases. A subset of kinases, the understudied dark kinases (DKs), have received little
or no attention because foundational data on their biochemical and biological functions is not available. This
proposal will collect such data by perturbing DKs genetically and with small molecules and then measuring the
cellular consequences using multiplex proteomic, gene expression, metabolomic and imaging assays. A
subset of DKs with potential links to human disease will be intensively studied as a means to qualify new
therapeutic drug targets. Data collected in this project will be aggregated with existing information from
previous NIH-funded large-scale structural and genomic projects to create a Dark Kinase Knowledgebase
(DKK) that provides gene-by-gene and network-level information on the dark kinome and its interaction with
other signal transduction and regulatory networks. Close coordination with the NIH LINCS project will ensure
data interoperability and make efficient use of informatics tools. The DKK will be developed in collaboration
with the IDG Knowledge Management Center (KMC), adhere to standards for Findable, Accessible,
Interoperable and Reusable (FAIR) data, and be accessible to human users and machines (via an API).
Commercially available DK reagents be validated and extended with new genetic and chemical tools provided
to the Resource Dissemination Center (RDOC). The overall approach will be iterative, with simpler methods
applied first (e.g. simple gene knockout) and more sophisticated methods subsequently (e.g. stable
CRIPSRa/i) pursued by an interdisciplinary team of chemists, computational biologists, mass spectroscopists
and pharmacologists working on five linked aims. Aim 1 will develop a computational algorithm for prioritizing
DKs, develop and maintain the DKK, and perform network-level analysis on the kinome using supervised and
unsupervised machine learning. Aim 2 will measure kinase abundance in normal and perturbed cells using
parallel reaction monitoring with stable isotope dilution (PRM-SID) and RNASeq and data analyzed using
network inference tools to provide insight into dark and light kinome in diverse cell types. Aim 3 will perturb
DKs with genetic tools such as CRIPSR/Cas9-mediated gene knockout, CRIPSRa/i to induce more subtle-up
and down regulation and inducible gene inaction. The impact on cell fate, morphology and signal transduction
will then be determined using PRM-SID, phosphoproteomics, RNASeq, gene reporter assays, metabolomics
profiling and highly multiplex single-cell imaging. Aim 4 will extend DK analysis to small molecule inhibitors by
carefully profiling existing drugs against DKs and by designing and synthesizing new chemical ligands. Aim 5
will involve collaboration with other investigators to assay the expression and function of DKs in primary human
cells and tissues relevant to the NIH Precision Medicine Initiative. All aims will be pursued in parallel for a
progressively expanding resource of data and tools for continued study of DKs.

Public health relevance
Project Narrative/Health Relevance Advancing understanding of understudied kinases, a highly druggable class of proteins, will increase knowledge about signal transduction and control over cellular physiology and is likely to reveal a subset of proteins that should be advanced as targets for new therapeutic drugs.